Contributions of educational quality and occupational complexity on racial and ethnic inequities in brain health and Alzheimer's disease and related dementia

ABSTRACT
By 2050 nearly 14 million people will suffer from Alzheimer's disease and related dementias (ADRD) in the US
and minorities will be disproportionally burdened. While it is known that certain racial/ethnic groups, such as
African Americans, have higher rates of dementia, reasons for disparities are unknown. Though education and
occupation are robustly associated with ADRD, research on education quality and occupational complexity has
primarily included only Whites or, when examining racial/ethnic differences, focused on comparisons between
Whites and African Americans. We propose to examine the role of educational quality and occupational
complexity on cognitive decline, ADRD, and imaging markers of vascular brain injury and neurodegeneration in
a cohort with unparalleled racial/ethnic diversity. The proposed study derives measures of education quality
and occupational complexity, building upon the following rich data sources at Kaiser Permanente Northern
California: detailed social and physical measures from a Multiphasic Health Checkup completed during the
1960s to 1990s; electronic medical records from 1996 onward; and detailed social, cognitive, and
neuroimaging measures from the Kaiser Healthy Aging and Diverse Life Experiences (KHANDLE) study
assessments. KHANDLE collects the names and locations of schools attended at 1st, 6th, 9th, and 12th grades
as well as college or university attended which will be linked to historical indicators of school quality.
Comprehensive information collected regarding occupation enables delineation of occupational complexity in
early-, mid-, and late-adulthood. Utilizing these comprehensive data sources, we are in a unique position to
successfully complete the aims of the study, which are to: 1) Evaluate the roles of education quality on
cognitive decline, ADRD incidence, and imaging markers of vascular brain injury and neurodegeneration in
African American, White, Asian, and Latino individuals; 2) Examine the role of occupational complexity on
cognitive decline, ADRD incidence, and imaging markers of vascular brain injury and neurodegeneration in this
diverse cohort; 3) Delineate if patterns of educational quality and occupational complexity across the lifecourse
mediate racial and ethnic disparities in ADRD, cognitive decline, and imaging markers of vascular brain injury
and neurodegeneration. Utilizing a lifecourse approach, as recommended by the NIH State of the Science on
Preventing Cognitive Decline, the proposed research will add vital information regarding the characteristics and
timing of education quality and occupational complexity characteristics associated with ADRD and may inform
future interventions aiming to improve cognition among elderly of all racial/ethnic groups. Given the marked
disparities in ADRD rates by racial/ethnic groups there has never been a more critical time to understand how
sociocontextual risk factors impact brain health in diverse populations.

Public health relevance
PROJECT NARRATIVE Education quality and occupational complexity are known protective factors against Alzheimer's disease and related dementias (ADRD), which are major public health problems that disproportionately burden several minority groups, yet the majority of research is conducted among primarily White populations or examines differences between Whites and African Americans. Including more racially diverse populations in research provides major opportunities for understanding the determinants of ADRD. The results of this project will further define our knowledge of education quality and occupational complexity as protective factors against cognitive decline and ADRD in a diverse cohort and assess their possible role as drivers of racial and ethnic inequalities in heathy brain aging.